Development of an Orthosis with an Integrated Microphone for Measurement of Knee Acoustic Emissions in Pre-Radiographic Osteoarthritis

This is an application for a Small Projects in Rehabilitation Research (SPiRE) award to Dr. David Ewart, MD, a
staff rheumatologist at the Minneapolis VA Medical Center and Assistant Professor at the University of
Minnesota. Dr. Ewart has a history of research and publications in biomechanics, immunology, and animal
models of arthritis and is transitioning to a focus on the treatment and rehabilitation of joint damage. Dr.
Ewart is an early career investigator with protected time to establish an independent line of investigation. This
SPiRE award will provide Dr. Ewart with the support to: 1) develop a unique interinstitutional collaboration to
build an orthosis with an integrated microphone to measure acoustic emissions from the knee at the point of
care 2) use acoustic emissions to identify patients with pre-radiographic osteoarthritis of the knee 3) establish a
mentored role in a busy research group and generate the preliminary data with which to apply for a career
development award (CDA-2). To achieve these goals, Dr. Ewart has established a mentorship team consisting
of Dr. Andrew Hansen, head of the Minneapolis Adaptive Design and Engineering (MADE) program at the
Minneapolis VA, and Dr. Omer Inan, PhD, Associate Professor of Electrical and Computer Engineering at
Georgia Tech. Dr. Ewart will work with the MADE program to perform the technical construction of the knee
orthosis, integrate the microphone into it, and collaborate remotely with Dr. Inan to analyze the data from and
refine the microphone system for function in the wearable device.
Osteoarthritis (OA) is a prevalent and disabling disease. Pharmacologic and surgical treatments for symptoms
of OA are insufficient for many patients and there are no therapies which halt or even delay the structural
progression of disease. One difficulty in the study of such therapies is identification of patients at an early
enough stage of disease that the damage to the joint is potentially reversible. In patients at risk of OA but with
no signs of it on x-rays, MRI has been shown to be able to identify changes in the knee that are predictive of
subsequent development of OA. However, these findings are not specific in all circumstances and MRI is
expensive, time-consuming, and can’t be used at the point of care. Measurement of acoustic emissions from the
knee with a modern, miniature microphone can differentiate health in the knee from disease and would offer
novel method of screening for early OA. In Aim 1, Dr. Ewart will work with the MADE program and Dr. Inan’s
group to prototype and iteratively design a portable orthosis with an integrated microphone system for
measuring acoustic emissions from the knee at the point of care. In Aim 2, Dr. Ewart will identify patients at
risk for development of osteoarthritis of the knee but without radiographic signs of advanced disease and
compare acoustic emissions from their knees to healthy controls. If acoustic emissions are abnormal in the at-
risk group, MRIs of their knees will be obtained to assess for findings that predict development of radiographic
and symptomatic progression to OA, validating the ability of acoustic emissions to diagnose early OA. The
overall objective of the proposed project is to develop a portable orthosis capable of measuring acoustic
emissions from the knee at the point of care to identify patients with early pre-radiographic OA. Dr. Ewart’s
long-term goal is to develop technology for non-invasive monitoring of joint health and function that can
provide useful clinical information to providers that will result in patient-specific therapies, custom orthotics,
and ultimately improved symptoms, function, and joint longevity. This work will form the basis for further
mechanistic, clinical, and translational investigation into the basis for pathologic acoustic emissions and their
application to osteoarthritis. These studies will be proposed in a CDA-2 award application at the end of the
SPiRE funding period.

Public health relevance
Osteoarthritis is the most common cause of disability in the United States. It is even more common in Veterans than the general population, is the primary source of disability in combat-wounded veterans, and is the most common reason for a service member to be removed from active duty. Developing treatments that delay or reverse the joint damage of osteoarthritis has been difficult partly because the disease is not evident on x-rays until it is far advanced and likely not reversible. Microphones can be used to measure noise created by a damaged joint and are able to identify a healthy knee from one with disease. The goal of our project is to build a portable knee brace with an attached microphone that will measure noise from the knee in common clinical settings. This allow prompt identification of Veterans with early osteoarthritis and allow for therapies that prolong joint lifespan.